TARGETED ANTIGEN PRESENTATION

Bispecific antibodies can greatly enhance the ability of an antigen to evoke an antibody response, in mice, paralleling their ability to enhance antigen processing and presentation in vitro.